Repurposing FDA-approved drugs for the treatment of osteoarthritis using high-throughput screening in microphysiological models

Abstract: Osteoarthritis (OA) is a painful and disabling joint disorder affecting more than 30 million Americans.
Current treatments for OA are primarily to relieve pain and maintain mobility, and none of them are clinically
demonstrated to reverse OA progression. Developing novel disease-modifying OA drugs (DMOADs) is
challenging because there are no demonstrated molecular targets. The heterogeneous clinical presentations of
OA add additional barriers to developing DMOADs. While global efforts are being channeled into
understanding each OA endotype and discovering novel compounds, repurposing FDA-approved drugs
represents a cost-efficient and time-saving solution to develop DMOADs, given that their safety in humans has
been previously validated. In particular, three primary OA endotypes have been identified, which include 1)
cartilage-driven endotype, 2) bone-driven endotype, 3) inflammation-driven endotype. Selectively targeting
these three endotypes represents a practical and generic strategy to discover DMOADs from the FDA-
approved drugs. Importantly, repurposing thousands of FDA-approved drugs needs to be performed on a
platform possessing high-throughput screening capacity. The current OA animal models are not compatible
with such a large-scale study. In addition, the preclinical efficacy of novel therapeutics defined in animal
models is poorly translated in clinical trials, raising concern about their predictive utility. Therefore, for drug
repurposing, using human cell-derived in vitro models that can selectively stimulate OA endotype(s) represents
a feasible and efficient strategy. Recently, we developed an OA cartilage model by chondroinducing in vitro-
aged human mesenchymal stromal cells (hMSCs), which simulated many key changes observed in OA
chondrocytes. In addition, we have mixed hMSC-derived fibroblasts and human monocyte-derived
macrophages to simulate the two key cell types in synovial membranes: fibroblast- and macrophage-like
synoviocytes. To overcome the limitation of these single-tissue models in simulating tissue crosstalk in disease
progression and drug treatment, our team has also generated an in vitro microphysiological joint chip (miniJoint)
that integrates the osteochondral, synovial, and adipose analogs. In this application, we propose to use the
three in vitro models to repurpose FDA-approved drugs for OA treatment by defining their capacity to reverse
cartilage and/or inflammation-driven endotypes. The drug library (~2,400) will be first screened with cartilage
and synovial models, and the most promising compounds and their combinations will be further examined in
the miniJoint model. To overcome the limitations of using primary cells, such as finite cell number and donor-to-
donor variation, all three models will be created by human induced pluripotent stem cells (hiPSC). The
successful completion of this study will generate a potential DMOAD pool that is ready for study in animal and
human clinical trials. Testing different combinations of these drugs at varying doses in the human cell-derived
miniJoint model will also facilitate a personalized approach to the treatment of OA.

Public health relevance
Osteoarthritis (OA) is a painful and disabling joint disorder affecting more than 30 million Americans, and none of the current treatments for OA are clinically demonstrated to reverse OA progression. In this application, we propose to use the in vitro models to repurpose FDA-approved drugs for OA treatment through high-throughput screening. The successful completion of this study will generate a potential drug pool that is ready for study in human clinical trials.